Endocrinology and Metabolism Training Program

PROJECT SUMMARY/ABSTRACT
The Endocrinology and Metabolism Research Training Program (Endocrinology T32) at Duke University
Medical Center seeks to identify, recruit, and train the next generation of biomedical scientists so that
they can continue growing as part of the national research workforce. The program centers on
investigators in the Duke Division of Endocrinology, its affiliated research centers, and other collaborating
Divisions and Departments at Duke. The topical focus of this program is research related to diabetes,
obesity, and metabolic diseases. Postdoctoral participants in this program will be either board-eligible or
board-certified physicians with training in Internal Medicine, Surgery, or Pediatrics, or PhD scientists
pursuing careers in diabetes and metabolic investigation.
The Duke Endocrinology T32 has a long track record of training successful investigators in diabetes,
metabolic bone disease, and other areas of related research. A substantial majority (80% of trainees
over the past two cycles of the grant) remain in academic positions at major medical centers across
the US and abroad. Most are in positions with substantial research components, supported by federal,
foundation, or industry grants, and the remainder have significant teaching responsibilities.
The program provides world-class research training opportunities across four domains (basic,
translational, clinical, and health services/implementation research) and three cross-cutting areas
(diversity, equity, and inclusion; community engagement; inter-center collaboration). Our T32 mentors
maintain funded research programs in basic science (e.g., islet biology, mitochondrial function and
energetics, metabolic flux, transcriptional regulation of metabolism), preclinical physiology using mouse
genetic models, clinical physiology in humans (e.g., insulin secretion, incretin action, exercise and
metabolism, bariatric surgery), clinical outcomes research (e.g., clinical trials and epidemiology), and
health services and implementation research (e.g., care delivery innovations in diabetes and weight
management). Trainees choose primary mentors and mentoring teams, but also have access to the full
breadth of our T32 faculty cohort through collaborations, didactic teaching and seminars. Training
focuses on identifying important research questions, formulating incisive hypotheses, and designing
straightforward but dispositive experiments; technical and analytic proficiency will also be stressed.
Importantly, trainees will be challenged to develop their communication skills, both for oral and written
communication, with an emphasis on grant writing. Individuals completing the program will be well-
positioned to obtain career development awards to support their continued growth as independent
investigators, and will be able to translate their research into significant clinical advances.

Public health relevance
PROJECT NARRATIVE Diabetes is a public health epidemic, with a prevalence of greater than 10% in the United States. Diabetes and associated metabolic disorders cause significant health complications and generate enormous costs for healthcare systems. In order to develop new and more effective treatments and care strategies for those affected by diabetes and other metabolic disorders, there is a critical need for researchers in this space who can change the course of diabetes through discovery, analysis, and development of new care strategies. The Duke University T32 Research Training Program in Endocrinology and Metabolism will leverage its world-class faculty, resources, and environment to combat the diabetes epidemic by recruiting and training outstanding physicians and medical scientists for careers in diabetes and metabolism research.